Molecular mechanisms of gasdermin recognition by proteases and autophagy proteins in cytokine release

Abstract
The goal of this proposal is to investigate mechanisms for pyroptosis-dependent and novel pyroptosis-
independent export of proinflammatory cytokines mediated by caspases, secretory autophagy proteins, and
gasdermin D (GSDMD), a recently identified effector molecule for pyroptosis. The inflammasomes are crucial
innate immune signaling platforms implicated in immune defense against infections and autoimmune/
autoinflammatory disorders such as inflammatory bowel disease, multiple sclerosis, and Alzheimer’s disease.
Activation of the inflammasome signaling pathways leads to the maturation and secretion of cytokines such as
IL-1β and IL-18, and an inflammatory form of programmed cell death in certain cell types called pyroptosis.
GSDMD assembles membrane pores upon cleavage by inflammatory caspases-1, 4, 5 and 11 and caspase-8.
In macrophages, such pores allow the release of mature cytokines upon cytolysis. Intriguingly, pyroptosis- and
membrane pore-independent function of GSDMD during secretion of IL-1β upon inflammasome activation has
been demonstrated for neutrophils, epithelial cells and T cells (Projects 1, 2, and 4), in which GSDMD is recruited
by secretory autophagy proteins to facilitate a novel non-lytic form of cytokine release. Specific recognition of
GSDMD by caspases or autophagy proteins thus underlie GSDMD function in lytic or non-lytic cytokine release.
We hypothesize that inflammatory caspases recognize GSDMD through distinct protein-protein interfaces during
lytic cytokine release. By contrast, GSDMD is recruited by autophagy machinery to facilitate novel non-lytic
cytokine secretion independent of membrane pore formation. We will focus on the following specific aims in a
collaborative Program Project to test the above hypothesis. Aim 1. Define the mechanisms of protease-
dependent activation of GSDMD in lytic release of cytokines. We propose to elucidate the mechanisms of
GSDMD recognition by caspases and serine proteases in collaboration with Projects 1, 2 and 4. Discovery from
our proposal may facilitate investigation into specific caspase inhibitors based on distinct enzyme-substrate
interfaces, which may target pyroptosis, apoptosis and other inflammatory signaling pathways involving
caspases. Aim 2. Define the mechanisms of GSDMD-guided non-lytic secretion of cytokines. We propose to
characterize the recruitment of IL-1β and GSDMD by chaperones and autophagy proteins. The roles of these
interaction in non-lytic cytokine release will be probed in collaboration with Projects 2 and 4. The success of this
project will reveal the molecular mechanisms for the lytic or non-lytic secretion of proinflammatory cytokines
mediated by GSDMD. This proposal draws on the strength of the other three Projects to facilitate and validate
our structural studies. Structural insights from our studies will in turn inform experimental design and data
interpretation for the other Projects. As such, outcomes from the four Projects benefit each other as an
interdependent and integrated Program.

Public health relevance
Relevance Inflammasomes play important roles in immune defense against infections and autoimmune/autoinflammatory disorders such as inflammatory bowel disease, multiple sclerosis, and Alzheimer’s disease. Activation of the inflammasomes lead to maturation and secretion of proinflammatory cytokines and pyroptosis, a highly inflammatory form of cell death that triggers cytolysis accompanied by cytokine release. Intriguingly, pyroptosis- and membrane pore-independent function of GSDMD in secretion of cytokines has been demonstrated in neutrophils, epithelial cells, and T cells. The goal of this proposal is to probe mechanisms for pyroptosis- dependent and novel pyroptosis-independent release of proinflammatory cytokines mediated by GSDMD. The outcome will not only provide novel insights into lytic and non-lytic cytokine release, but may also stimulate the development of therapeutics that target inflammatory disorders.!